Fungal-bacterial dynamics driving dysregulated host responses and lethal synergism

Polymicrobial infections involving fungal and bacterial pathogens are increasingly common among hospitalized
patients. However, there is a paucity of research focused on studying polymicrobial infections. The fungal
pathogen Candida albicans is the most common cause of invasive fungal infection and the third most common
cause of nosocomial bloodstream infections in the US. Invasive fungal infections with C. albicans have
devastatingly high mortality rates compared with bacterial infections. Bloodstream fungal infections, which are
mostly monomicrobial, result in a 40% mortality rate. In contrast, intra-abdominal fungal infections (IAI), which
are often polymicrobial involving both fungal and bacterial species, result in a 50-75% mortality rate, which far
exceeds bacterial mono- or polymicrobial IAI mortality rates (20%). Fungal involvement also leads to increased
rates of relapse and more severe disease scores. The mechanisms associated with this exacerbated mortality
are currently unknown. The objective of this proposal is to delineate host and microbial mechanisms contributing
to synergistic lethality during polymicrobial fungal-bacterial IAI. Our central hypothesis is that polymicrobial
fungal–bacterial IAIs promote synergistic effects on mortality induced by microbe-microbe interactions that
increase bacterial toxin production, leading to upregulation of immune signaling pathways, dysregulation of
hemostasis and coagulation, and altered bone marrow remodeling. This hypothesis will be tested by modeling
polymicrobial interactions with C. albicans and the Gram-positive bacterium Staphylococcus aureus, which is
the most commonly co-isolated bacterial pathogen from fungal-bacterial co-infections. The first specific aim of
this project is to interrogate the mechanisms by which Candida induces of S. aureus toxin production during
polymicrobial IAI. The second specific aim will define bacterial mechanisms and virulence regulators that drive
dysregulated hemostasis and coagulation that contribute to lethality during polymicrobial IAI. The third specific
aim will functionally characterize the consequences of Candida-induced S. aureus toxin production on bone
marrow homeostasis and trained innate immunity. Completion of this project will identify both new mechanisms
that underlie exacerbated pathogenicity of polymicrobial infections and therapeutic approaches to improve
outcomes of IAI.

Public health relevance
Intra-abdominal infections (IAI) with fungi and bacteria concurrently result in worsened outcomes as compared to monomicrobial or bacterial co-infection, although the reasons are not fully understood. Our previous work to recapitulate IAI in a murine model using the fungus Candida albicans and bacterium Staphylococcus aureus as model organisms has identified Candida-induced bacterial toxin production as a key driver of pathological inflammatory responses and lethality. The major goal of this work is to delineate the host and microbial mechanisms involved in promoting lethality and altering protective trained innate immunity in order to develop better therapeutic interventions to prevent the high mortality observed during fungal-bacterial IAI.